Getting Regenerative Medical Biotech REDI to Age

The potential outcomes of this application include: (1) Curriculum development and the creation of internship opportunities within an entrepreneurship in biotechnology focused program; (2) a greater representation of well-trained researchers within biotech entrepreneurship in Southeast Louisiana with the potential to expand across the U.S.; (3) a tangible number of students who can go on to pursue advance degrees and employment opportunities within the biotechnology sector; and (4) a pipeline of individuals who will value the importance of the responsible conduct of research, and apply those ethics to create their own companies as entrepreneurs, or their own training programs as educators or researchers within various biotechnology fields. This Small Business Innovation Research application addresses an identified challenge and unmet gap in curriculum development that combines exposure to fundamental concepts in both biotechnology research and entrepreneurial development and provides a pathway to create opportunities for a forward-thinking and agile biotechnology workforce. Unlike existing curricula, the proposed programming does not have the goal of promoting careers exclusively in academia or biotechnology. The intention is to leverage the background and training of professionals at Obatala Sciences, Delgado Community College, Xavier University of Louisiana, and the University of New Orleans, to give students greater insight into the opportunities that exist and the relevance of maintaining the responsible conduct of research within all stages of their career. Such a program is a complement to any set of traditional business and/or research courses and provides a mechanism to reinforce some of the necessary elements of success within research in biotechnology and entrepreneurship. Obatala anticipates achievement of the following outcomes: Firstly, it will implement coursework and accompanying teaching tools that focus on entrepreneurship in biotechnology and are adaptable across multiple teaching platforms and programs that are designed to give greater exposure to opportunities in entrepreneurship. Secondly, it will create a pipeline of interns and professionals who can apply lessons learned from their executive MBA or entrepreneurship programs to multiple facets of their careers and take these fundamentals with them to other opportunities throughout the nation. Thirdly, it will create a success metric that can be applied to programs that are designed to promote cross pollination of ideas within in research and entrepreneurship. By incorporating one or all these innovations to the current approach to teaching biotechnology, Obatala will introduce an adaptable teaching model with impacts spanning academic and industry researchers and entrepreneurs, across fields including therapeutics and regenerative medicine. Obatala will position itself as a leader that supports training the next generation of researchers and promoting the highest standards of ethics and the responsible conduct of research. Such activity has potential to positively impact the current perception of the role of entrepreneurship in research on a global scale.

Public health relevance
The current proposal combines exposure to fundamental concepts in both biotechnology research and entrepreneurial development and provides a pathway to create opportunity for a well-trained, highly skilled workforce. The outcomes will provide a fundamental appreciation for the ethics of responsible conduct in research and a mechanism to reinforce some of the necessary elements of success within research in biotechnology and entrepreneurship.